RELATIONSHIP OF HEARING LOSS IN INFANTS TO MATERNAL CMV IMMUNE STATUS

This project is designed to study the relationship between the occurrence of hearing loss and other neurodevelopmental abnormalities occurring in children with congenital cytomegalovirus and maternal seroimmunity during pregnancy to determine if infants with abnormalities are born only to mothers with primary infections.